Admin-Core

The Management and Administrative Core of this proposed Roybal Center will be led by Overall Principal
Investigator Scott Halpern, MD, PhD, with assistance from the other members of the Center's Steering
Committee. The central goal of this Core is to provide the infrastructure and expertise necessary to support the
design, testing, and dissemination of behavioral interventions that improve palliative care for persons with
dementia (PWD) and their caregivers in long-term services and support (LTSS) facilities across the U.S.
Several characteristics of the Center and its investigators position us uniquely well to achieve this goal.
First, we have partnered with dozens of external, non-academic healthcare organizations during the past
decade, and have thus learned how to align our work with institutional priorities, problem-solve in unfamiliar
environments, and assist organizations that are not accustomed to conducting research in ensuring
appropriate safeguards and human subjects research protections. This experience will enable us to capitalize
on our tremendous opportunity to produce generalizable evidence of the effectiveness of scalable interventions
by conducting our pilot projects within LTSS facilities owned by Genesis HealthCare, the nation's largest LTSS
company. Second, we have considerable experience developing and testing behavioral interventions to
improve advance care planning, symptom management, and other palliative care services for PWD in LTSS
facilities including nursing homes and assisted-living facilities. Third, several Center investigators are among
the world leaders in the design, conduct, and ethics of large, pragmatic trials, particularly trials testing
behavioral interventions. Fourth, our investigators include leaders of several other NIA-supported Centers,
facilitating collaborations, shared resources, and other efficiencies in conducting impactful research.
Finally, this new Roybal Center will directly leverage the existing resources of two robust, multidisciplinary
research centers at Penn: the Palliative and Advanced Illness Research (PAIR) Center, and the Penn Memory
Center. We will also benefit from formal linkages with Penn's hubs for behavioral economics (the Center for
Health Incentives and Behavioral Economics) and biomedical informatics (the Institute for Biomedical
Informatics). To achieve its overall goal, this Core has seven specific aims, including to: plan, implement, and
coordinate all Center activities such as the annual Symposium; engage and manage the Center's Advisory
Committee; develop new strategic collaborations with other LTSS companies; grow our national network of
Affiliated Investigators working to improve residential palliative care for PWD; foster collaborations with other
NIA-supported Centers; oversee data linkages that will enhance the efficient measurement of the effects of our
interventions; and disseminate the Center's findings through a coordinated communications strategy.